Molecular Mechanisms of Filoviral-host Interactions

Overall Project Summary/Abstract: Molecular mechanisms of filoviral-host interactions
The family Filoviridae, which includes Ebola virus (EBOV) and Marburg virus (MARV), are zoonotic pathogens
that cause outbreaks of severe human disease and require biosafety level 4 (BSL4) containment for study.
Recent approval of a vaccine and antibody-based therapies against an EBOV represent progress towards
medical countermeasures. However, the family is comprised of multiple antigenically distinct species, making
identification of pan-filoviral therapeutic approaches desirable. Furthermore, the molecular mechanisms required
for replication and pathogenesis are incompletely understood. Defining key filovirus-host interactions and the
mechanisms by which they promote viral growth and disease will provide important insight into viral biology and
suggest new therapeutic approaches. Existing data, including our own, have identified key host-viral interactions
that likely play important roles in the pathogenesis of filovirus disease. Our overarching goal is to address this
gap in knowledge by building and expanding upon the strong foundational knowledge on EBOV to define
molecular mechanisms at the host-pathogen interface and to identify EBOV-specific and pan-filoviral interactions
that contribute to pathogenesis. To achieve our goals, we have assembled a highly accomplished team with
track records of effective synergistic collaboration and expertise ranging from molecular biochemistry, structural
biology and mass spectrometry to cell biology, virology, and work at BSL4. In the current funding period, we
identified multiple host pathways that impact EBOV infection and defined key interactions at the viral-host
interface. In our proposed studies, we use a reductionist approach to define molecular mechanisms by
biochemical and structural methods (Project 1; RP01), determine the cellular impact and contributions of viral
proteins such as VP30 and VP24 in immune response, viral replication, assembly and egress (Project 2; RP02),
and evaluate the impact of specific interactions with EBOV and MARV virus in cell culture and in vivo, including
specific subnetworks that regulate filoviral entry and replication (Project 3; RP03). Recognizing the complexity
of the data being generated we have recruited new expertise in proteomics and genetic network analysis to
provide a deeper understanding of host-virus protein connectivity and interaction. These efforts will be further
supported by two scientific cores, the Antibody and Reagent Development Core B and the BSL4/ABSL4
laboratory Core C. This work will be guided by an active Administrative Core A that will receive critical input from
the Core A Advisory Group (CAAG) and the External Advisory Board (EAB). Each is comprised of preeminent
scientists in academia and industry with strong productivity in emerging infectious diseases and immunology and
significant advisory experience. Building on our productive initial work, we are poised to define a comprehensive
host interaction network, validate regulatory mechanisms that drive viral infection, and identify targets for
therapeutic intervention. Our unique innovative experimental framework and highly interactive scientific
approach provides a blueprint to tackle other emerging and reemerging pathogens.

Public health relevance
Overall PPG Narrative: Molecular mechanisms of filoviral-host interactions Ebola virus and Marburg virus are important emerging pathogens with significant potential to impact global public health. Host-viral interactions contribute to disease course and dictate the impact of infection but are incompletely defined for filoviruses. We will address this gap through a multidisciplinary approach that will identify, validate, and characterize filoviral proteins and associated host factors to shed light on critical interactions that drive viral replication and new therapeutic targets.